A COMPANION DIAGNOSTIC FOR PROGNOSIS OF KIDNEY CANCER

This contract was awarded by the National Cancer Institute's Small Business Innovative Research (SBIR) and Small Business Technology Transfer (STTR) Program under the funding opportunity "Contract Topic: 277 Companion Diagnostics: Predictive and Prognostic Tests Enabling Personalized Medicine in Cancer Therapy."